Life Course Center External Innovative Network Core

Project Summary/Abstract: External Innovative Research Network
The Network for Data-Intensive Research on Aging (NDIRA) will support an emerging interdisciplinary
community of scientists using novel collections of cross-sectional, longitudinal, and contextual data for research
on population aging. NDIRA will bring established scholars of aging together with scholars new to the field and
introduce them to data that are fundamental to understanding health outcomes at older ages. By fostering
communication and collaboration, as well as providing hands-on assistance in data management and analysis,
we will contribute to both the talent pool and the data resource pool for addressing the demography and
economics of aging.
Innovative NIA-supported data infrastructure projects are opening new opportunities for
understanding trends and disparities in population aging, the impact of early life experiences on later life
outcomes, and the effect of changing economic, familial, environmental, geographic, cultural, and institutional
contexts on the older population. Many of these new data sources pose significant challenges for researchers
because of their large scale, complex structure, or restricted access. NDIRA is designed to mitigate these
challenges by fostering a community of scholars that will draw on novel data sources for research on aging. The
Core will promote research that addresses key priorities of the NIA’s Division of Behavioral and Social Research.
NDIRA will (1) build a broad community of researchers engaged in data-intensive research on aging; (2) identify
and address common problems faced by those researchers; and (3) engage new users and increase the diversity
of the research community.